The ADHINCRA Study: Addressing HypertensIoN Care in AfRicA

Project Summary/Abstract
Innovation in chronic disease management is urgently needed to effectively control hypertension (HTN) in
Ghana and Nigeria. Both countries are suffering silent epidemics of chronic diseases with rates closely
resembling those of high-income countries. Uncontrolled HTN causes cardiovascular disease, stroke, chronic
kidney disease, and premature death. However, HTN is poorly controlled in both countries due to patient-,
provider, and system-level barriers. A pressing global health challenge is implementing evidence-based and
contextually appropriate strategies to improve chronic disease management in Ghana and Nigeria. Multilevel
interventions improve HTN control. For instance, team-based care, a health systems-level and organizational
intervention, improves the quality of HTN care. Telehealth can be enhanced with home blood pressure
monitoring (HBPM) to address patient-, and provider-level barriers. The COVID-19 pandemic has spurred
efforts to increase access to timely and appropriate care through re-engineering primary care to be patient-
centered and digitally enabled. Sphygmo Home, a remote telemonitoring app that links with validated blood
pressure (BP) and glucose monitoring devices, is a promising solution to improve patients’ self-management of
chronic disease. In a previous pilot study, we investigated the impact of a multilevel and digitally-enabled home-
based intervention compared to enhanced usual care (UC). After 12 months, 80.5% in the intervention arm,
compared to 24.2% in the enhanced UC arm, had controlled BP (p <0.001). Given the promising findings, we
designed a larger scale trial, consisting of an innovative multilevel intervention linking HBPM with a
telemonitoring platform (Sphygmo Home app), team-based care including physicians and nurses, and the
use of simplified hypertension treatment protocol at hospitals, to improve HTN control. Using a hybrid type 2
effectiveness-implementation design among 800 adults with uncontrolled HTN clustered in 16 hospitals
across 3 regions (Ashanti, Northern, and Bono) in Ghana and in Ondo state, Nigeria, we seek to 1) Assess the
effect of the ADHINCRA Program in improving BP control at 12 months using a stepped wedge cluster
randomized trial of adults with uncontrolled HTN (systolic BP ≥140 mm Hg) and 2) Use the Pragmatic Robust
Implementation and Sustainability Model (PRISM) to evaluate the reach, adoption, and maintenance of the
ADHINCRA Program at 12- and 24-months post-randomization and explore contextual factors that are
associated with the adoption and maintenance of the program in each site using the Service Availability and
Readiness Assessment (SARA) tool. Through early and continued stakeholder engagement with health system
leaders, providers, and patients, we seek to close the wide “know-do-gap” and reduce global chronic disease
disparities. We also propose a comprehensive dissemination strategy to reach critical audiences and achieve
buy-in, policy, and practice change.

Public health relevance
Project Narrative To successfully control hypertension in Ghana, Nigeria and Africa, we need new ways to treat chronic diseases. Even though there is a lot of proof about effective, long-term ways to control hypertension, these strategies have not been used equally in places with few resources, like Ghana and Nigeria. We want to see if the ADHINCRA Program, an innovative, patient-centered, program that includes home blood pressure monitoring, mobile health technology, team-based care with doctors and nurses, and adjustments to medicines by nurses using an adapted, simplified hypertension treatment protocol, improves hypertension control in Ghana and Nigeria compared to usual care.